RECOMBINANT HUMAN ERYTHROPOIETIN IN MYELODYSPLASIA AND MULTIPLE MYELOMA

This study is designed to assess the safety and efficacy of high doses of recombinant human erythropoietin in the treatment of patients with myelodysplasia (refractory anemia/pre-leukemia).